Core A: Administrative Core

ADMINISTRATIVE CORE - CORE A: ABSTRACT The BIOCARD study is a longitudinal, observational study of 349 individuals who were cognitively normal and primarily middle aged (mean age=57.1) at enrollment. Our overall objectives are to further advance the study of preclinical AD by: (1) clarifying the pattern and rate of changes in AD biomarkers (including CSF, MRI, amyloid imaging and blood) and cognition that occur during the earliest phases of AD, (2) maximizing our data by working collaboratively with several research groups who have comparable data, and (3) providing a publicly accessible database, to include biological specimens, for researchers in the field. To accomplish these goals we established 7 Cores. The Administrative Core (Core A) is essential for the overall functioning and coordination of the project. The specific aims include: (1) oversight and integration of the Cores in the project, (2) facilitation of collaborative research with investigators outside of Johns Hopkins University (JHU), (3) assurance of sound fiscal management, (4) assurance that all aspects of the project comply with local and federal regulations, (5) coordinating external review of the project through meetings of the Scientific Advisory Board and the Resource Allocation Committee, and (6) communicating with the staff of the National Institute on Aging (NIA) consistent with the guidelines of the FOA.